Amyloid Pathology and Cognition in Normal Elderly

DESCRIPTION (provided by applicant): In this competing renewal of our MERIT Award, the central goal is to further the understanding of the occurrence of asymptomatic amyloid-beta (Aβ) deposition and its progression to clinical cognitive impairment. During the previous eight years we collected Aβ imaging and cognitive data on 75 cognitively normal older adults to determine if the variability in cognition in this group was explained largely by Aβ deposition and found that it was not. This cohort has now matured to the point that the occurrence of incident Mild Cognitive Impairment (MCI) and incident Aβ-positivity [incident-Aβ(+)] is sufficient to address other important hypotheses that could not be properly addressed until sufficient follow-up was in place - as is the case now. One critical hypothesis that we can now test is that Aβ-positive cognitively normal older adults are at high risk to develop clinically-significant cognitive impairment (i.e., MCI) (Aim 1). In addition, our growing cohort of incident-Aβ(+) subjects allows us to observe the transition from being Aβ-negative to the earliest Aβ-positive [Aβ(+)] state (Aim 2.2). This enables us to measure the time spent Aβ(+) and avoids many other limitations of cross-sectional studies. Also, our longitudinal fMRI data in incident-Aβ(+) individuals will allow us to test for the first time the assumption that higher hippocampal activation in Aβ(+) individuals reflects a true increase from baseline, and not just a maintenance of lifelong high activation as suggested by studies of cerebral metabolism and will aid us in predicting when Aβ(+) individuals will develop cognitive decline (Aim 3). Finally, we propose to enhance our cohort to more effectively address the relationship between Aβ deposition and cognition by broadening the cognitive range of our cohort (Aim 2.1). We will do this in an innovative way by adding a group of individuals who do not meet criteria for MCI, but show mild neuropsychological deficits without cognitive or functional complaints. The overall impact and significance of this study will be to further our understanding of: 1) the incidence of asymptomatic β-amyloidosis; 2) the relationships between early Aβ deposition, hippocampal activation and cognition; and ultimately, 3) the relationship of asymptomatic β-amyloidosis and clinical MCI (and the timing of that association). We will continue to employ state-of-the-art neuroimaging methods (including the Pittsburgh Compound-B amyloid imaging technology developed by our group) along with both standard and innovative neurocognitive and clinical measures. Innovative aspects of this project include: 1) the study of incident MCI in Aβ(+) individuals; 2) the study of incident-Aβ(+) cases; and 3) the longitudinal study of the natural history of hippocampal activation in incident-Aβ(+) individuals and its relationship to progression to MCI. Completion of our study will result in a predictive model of MCI that will incorporate the Aβ and neurodegenerative parameters of the preclinical Alzheimer's disease (AD) criteria. This data will aid in the design and interpretation f existing and ongoing prevention trials for AD and thus have great relevance to the major public health threat posed by this disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: Our field has recently initiated four NIH-funded trials aimed at the prevention of Alzheimer's disease (AD) by targeting the amyloid-beta protein that is believed to start building up in the brains of many older adults as much as 10-15 years before any memory problems occur. However, we have no firm understanding of the time frame or risk of progression from this asymptomatic "amyloid-positive" state to the onset of memory problems and Alzheimer's disease. We propose to use state-of-the-art brain imaging to continue the study of a group of older adults who have already been studied by us for up to 10 years to assess how the amyloid-positive state leads to the development of memory problems and Alzheimer's disease, thus facilitating the interpretation of the ongoing prevention trials.